Rural Health Lifestyles: The role of demographic change and migration shifts on rural women's health

Project Summary
This project aims to use multiple secondary demographic and health data sets to identify the demographic and
behavioral pathways responsible for increasing rural mortality disadvantages for women. The goal is to first
determine how rural women’s mortality varies across county-level demographic factors and how it has changed
over time in the context of shifting demographic patterns that have brought new residents into rural regions due
to jobs, retirement, or Covid-19 migration. It also aims to understand how rural women’s health lifestyles or
combinations of health behaviors have shifted over time in response to new residents and the relative
consequences of these behaviors on health and mortality. By Identifying how these different compositional and
contextual county-level factors have changed over time across various degrees of rurality, ranging from the
least to most rural counties, we will ultimately identify the risk factors and potential intervention points to
increase the healthy lifespan for rural women.